ROLE OF CALCIUM, CALPAINS, AND CASPASES IN NEURODEGENERATION

The primary goals of this project are to determine the pathways involved in neuron death following insults implicated in aging and late-onset neurodegenerative disorders including Alzheimer's disease; to test the hypothesis that these pathways are, in part, Ca/2+ dependent; to assess the relative involvement calpain- and caspase-mediated proteolysis in the neuron death and cytoskeletal disruption; and to determine if an age-related increase in sensitivity to insults reflects increase propensity for apoptotic or necrotic neuron death. The mitochondrial toxin 3-nitropropionic acid (3NP, an irreversible inhibitor of succinate dehydrogenase) will be utilized extensively in these studies. 3NP-induced metabolic impairment can lead to neuron death via indirect excitotoxic insult resulting in necrotic death or via apoptotic mechanisms where the role of Ca/2+ and Ca/2+-dependent proteases is poorly understood. 3NP can be utilized in vitro and in vivo. The first specific aim will examine the hypothesis that following metabolic impairment induced by 3NP, apoptotic neuron death can occur via both Ca/2+-dependent and -independent mechanisms. The second aim will examine the relative contributions of Ca/2+-activated proteases (calpains) and cysteinyl aspartate-specific proteases (caspases) to the necrotic and apoptotic death. Distinct profiles of cytoskeletal disruption are predicated to be associated with necrosis, Ca/2+- dependent apoptosis, and Ca/2+-independent apoptosis. The third aim is to produce and characterize antibodies specific for caspase-mediated cleavage of cytoskeletal proteins. The third aim is to produce and characterize antibodies specific for caspase-mediated cleavage of cytoskeletal proteins. These antibodies will be utilized in aims four and five, along with biochemical and morphologic criteria, to characterize neuron death in vivo following metabolic impairment; to examine the hypothesis that blockade of excitotoxic death may unmask apoptotic mechanisms; to assess the age-related increase in vulnerability to metabolic impairment; and to evaluate the contributions of necrosis, Ca/2+-dependent-apoptosis and Ca/2+-independent apoptosis to the cytoskeletal disruption evident in Alzheimer's disease.